Rare Bronchiectatic Diseases Consortium

ADMINISTRATIVE CORE ABSTRACT
The mission of the Rare Bronchiectatic Diseases Consortium (RBDC) Administrative Core is to provide
comprehensive and sustained administrative, logistical, and operational support for all Consortium partners to
ensure the successful completion of the goals and projects associated with the RBDC. The Administrative Core’s
leadership and activities will enable the successful completion of our Consortium’s proposed research projects
aimed at improving our understanding of the pathophysiology of bronchiectasis in PCD, humoral immune
deficiencies (HID), STAT3 hyper IgE syndrome (STAT3-HIES), and alpha-one antitrypsin deficiency (α1AT),
which will lead to identifying clinical trial biomarkers/endpoints and potential therapeutic targets (treatable traits).
The RBDC Administrative Core will support the missions of the Pilot/Feasibility Governance and Career
Enhancement Cores, leading to future ancillary studies and the development of early-stage investigators. All
this work will be conducted in close partnership with our Patient Advocacy Groups (PAGs) to assure that the
voices of patients and families inform our strategy and critical decision-making. We will undertake five aims as
part of this core: Aim 1: Deliver comprehensive operational and organizational administration of the RBDC,
including the establishment and monitoring of standard operating procedures and policies, institutional review
board proposals, resource utilization, funds allocation, contractual agreements with our partnering research sites
and collaborating PAG and industry partners, monitoring of program milestones, and timely redress of potential
problems and dispute resolution. Aim 2: Direct and facilitate regular, productive communication among
collaborating investigators, institutions, and PAGs in a mutually supportive environment where each stakeholder
has a voice during critical discussions. Aim 3: Develop and maintain productive, collaborative working
relationships with investigators, PAGs, the NIH, the Office of Rare Diseases Research, the Observational Safety
and Monitoring Board, and industry partners. The Core will serve as the central point of collaboration with the
Rare Diseases Clinical Research Network (RDCRN) and the Data Management and Coordinating Center,
assuring best practices for handling and sharing data and biospecimens. Aim 4: Collaborating with the RDCRN
and PAGs, promote awareness of the purpose, progress, and meaningful outcomes of the RBDC to the clinical,
scientific, and relevant patient/stakeholder communities; partner with these groups to enhance the success of
the consortium and its impacts to improve the lives of patients and families. Aim 5: Establish an External Advisory
Committee consisting of scientific, clinical, and patient-stakeholder representatives who will regularly provide
consultation for the consortium to enhance operations and progress towards clinical trial readiness. The
Administrative Core will help assure that we achieve the RBDC’s ultimate goal of enhancing our understanding
of these rare diseases associated with bronchiectasis, ultimately leading to therapeutic targets and validated
clinical trial readiness tools.